Genetic Counseling Fellowship in Research Training (GC-FIRST)

SUMMARY
Due to expanded clinical implementation of genetic testing and technologies across healthcare specialties,
there is a huge demand for genetic counseling services in clinical, industry, public health, and academia. The
roles of genetic counselors have changed and grown drastically over the 40 years since the field's inception.
As the field has expanded to over 4,000, there is greater need for genetic counselors to be able to research the
practice in an evidence-based fashion. At present, a two-year Master’s Degree in Genetic Counseling
constitutes the terminal degree for genetic counselors, the majority who practice in clinic settings. While
genetic counselors are primed to study the profession in their current roles, additional research training is
needed to foster the necessary skills and methodology expertise to lead independent research programs. In
recognition that the field of genetic counseling would benefit from additional research funding and that our
research team is well poised to meet this need, we have created the first ever research fellowship for genetic
counselors called the Genetic Counseling Fellowship in Research Training (GC-FIRST) at the University of
Minnesota. Upon completion of this comprehensive 2-year, part-time research education experience, four
genetic counselors will be exceptionally well positioned to contribute to the growing need for genetic
counseling researchers. The overarching objective of GC-FIRST is to train genetic counselors in a range of
research methodologies to promote research implementation by genetic counselors working in clinical,
industry, public and population health settings. Our central goal is to educate genetic counseling researchers to
be independent leaders who mentor future genetic counseling researchers. To reach this goal and attain the
overall objective, we will: 1) Develop a rigorous qualitative and quantitative training in the fundamentals and
advances in genetic counseling research through a series of formal coursework and training modules; 2)
Provide interdisciplinary research training using a practical, application based, and collaborative approach to
produce two manuscripts and a grant application; 3) Generate a diverse cohort of well-trained research
clinicians that will have enthusiasm for lifelong learning to bolster the genetic counseling research workforce; 4)
Evaluate the short term and long term summative and formative outcomes of the two-year fellowship. If
successful, this application would create the first research training fellowship program for genetic counselors
and contribute to the workforce in academic, clinical, industry, public and population health settings. An added
end-product of the fellowship will be the creating and distribution of a set of online modules that will be
packaged to educate an even greater number of genetic counselors with advanced research training.

Public health relevance
NARRATIVE As the genetic counseling field has grown to over 4,000 and the profession has integrated across healthcare specialties, there is greater need for genetic counselors to be able to research the practice in an evidence-based fashion. Genetic counselors are primed to study the profession in their current roles, but additional research training is needed to foster necessary skills and methodology expertise to lead independent research programs in academia, clinic, industry, public and population health settings. To support this advancement of the field, we propose the first ever, two-year, part-time research fellowship for four genetic counselors called the Genetic Counseling Fellowship in Research Training (GC-FIRST) with the overarching aim to train genetic counseling research leaders and future mentors.